SENESCENT STROMA STIMULATES INFLAMMATION TO PROMOTE TUMORIGENESIS

Abstract
Age is a significant risk factor for the development of cancer. The mechanisms that drive this risk are complex
and involve both the accumulation of cell autonomous mutations within incipient tumor cells and pro-tumorigenic
changes in the tumor microenvironment. Investigation into the impact of an aging microenvironment on
tumorigenesis has revealed that senescent stromal cells can directly stimulate preneoplastic and neoplastic
growth. Because senescent cells accumulate with age, these observations raise the possibility that senescent
cells are an important contributor to age-related increases in tumorigenesis. To understand how senescent
stromal cells contribute to tumorigenesis, we developed the FASST mouse (Fibroblasts Accelerate Stromal-
Supported Tumorigenesis) that allows us to control the spatial and temporal activation of senescence in
mesenchymal cells. Using this mouse, we found that senescent mouse skin fibroblasts (MSFs) support increased
tumorigenesis in immunocompetent mice. Strikingly, we found that MSFs that arise independently of neoplastic
cells mediate their pro-tumorigenic properties by modulating the host immune system and creating
immunosuppression that limits CD8 T cell activity, thus allowing increased tumor growth. Previous work has
focused on the ability of senescent fibroblasts to directly stimulate tumor cell growth. Thus our work is the first to
show that senescent MSFs can promote tumor growth by modulating the immune system. Because we find that
senescent MSFs in our model cause localized recruitment of immunosuppressive cells, similar to what we find in
aging human skin, we propose that they contribute to age-related increases in tumorigenesis by creating regions
of local immune suppression that shelter incipient tumor cells and allow their outgrowth. To understand the
dynamics of immune modulation in the FASST model, we propose to determine the temporal pattern of immune
cell infiltration, the mechanisms that drive immune cell infiltration, and the senescence-specific factors that drive
the development and maintenance of the suppressive microenvironment present in the FASST mouse. Further
we propose to examine the impact of senescent stromal cells on a spontaneous model of squamous cell
carcinoma (SCC, K14-HPV16) where 100% of animals develop hyperplasia yet only 20% convert to SCC. Here
we propose that the activation of senescence within the stromal compartment will increase the penetrance in this
model by altering the immune landscape. Finally, we will ask how p38MAPK-dependent senescence-associated
secretory phenotype (SASP) factors contribute to the immunosuppressive environment created by senescent
stromal cells and ask in a preclinical setting if targeting p38MAPK or its downstream kinase MK2 is a valid
approach to reducing senescent stromal-supported tumorigenesis. Data from this proposal will provide vital
mechanistic insight and novel therapeutic targets that may reduce age-related increases in cancer.

Public health relevance
Relevance Statement Age is a significant risk factor for the development of cancer. We recently found that in addition to increasing tumor cell growth, senescent cells activate proteins that modulate the immune system and create an atmosphere of immune suppression that allows tumor cells to grow unabated. We will explore the impact of inhibition of these key proteins on immune modulation and tumor growth. Identification of these proteins will provide a better understanding of the process and, importantly, may provide novel therapeutic targets.